Design of fusion inhibitors to block measles host-to-host infection

Measles (MeV) causes disease worldwide despite efforts towards eradication by
vaccine, largely because it is spread so readily between people. Acute MeV infection
causes immune amnesia, resulting in increased susceptibility to other infectious
diseases. In addition, rare but severe neurological complications can develop several
years after measles due to persistent MeV infection of the central nervous system.
People with impaired cellular immunity are at increased risk of developing severe
measles, but often cannot be vaccinated since the vaccine virus itself can lead to fatal
illness. There is no specific therapy for acute or persistent MeV manifestations. A
successful vaccination campaign could have eradicated MeV more than 20 years ago.
As of today, eradication is not in sight and the resurgence of measles in the U.S. 2019
highlights the need for effective measures to prevent host-to-host transmission at the
moment of the outbreak surge. We have recently described a new MeV-specific fusion
inhibitor peptide that combines viral-specific targeting, self-assembling, and cell-
membrane integration leading to a MeV fusion inhibitor that outperformed our previous
fusion inhibitors in vitro and in vivo. This application will test whether this new inhibitor
prevents inter-host transmission and therefore fill this medical demand. We propose to
chemical engineer these inhibitors to optimize 1) the viral-specific targeting, 2) the
insertion on infected cells membrane, and 3) in vivo biodistribution. Our work will be
tested in vitro, ex vivo, and in vivo using a natural model of morbillivirus infection (Canine
Distemper Virus -CDV- in Ferrets).
1. To use protein engineering to optimize the self-assembling properties and
antiviral potency of HRC-peptide fusion inhibitors.
2. To evaluate the protection afforded by HRC peptide fusion inhibitors against
CDV infection in vivo and provide proof of concept for pre-clinical development.

Public health relevance
Measles causes a severe transient immunosuppression in healthy individual and severe complications in immunocompromised people. Recent U.S. outbreaks shows that 1 of every 600 measles infections in normal infants may also develop fatal measles encephalitis, underscoring the urgency of developing specific treatment for measles infection for the general population as well as for immune compromised individuals. Recent advances in our paramyxovirus research are ready to be applied to developing antiviral peptides to protect the individual and to halt measles host-to-host transmission.